Development of 1,2,4-Triazolyl Compounds and their derivatives as a New Treatment for Tuberculosis

PROJECT SUMMARY
Mycobacterium tuberculosis (Mtb) caused an estimated 1.6 million deaths in 2021. The emergence of drug-
resistant strains has exacerbated the epidemic, often rendering existing tuberculosis (TB) therapies inadequate
and revealing the dire need for new agents with unique mechanisms of action to combat the epidemic. Towards
this end, we have identified a new series of nitro-containing 1,2,4-triazole compounds that are potent inhibitors
of Mtb. Our preliminary data show that the nitro 1,2,4-triazoles retain activity in Mtb strains that are resistant to
the frontline antibiotics isoniazid and rifampicin, as well as moxifloxacin. In addition, we provide data that argues
against the nitro 1,2,4-triazoles inhibiting QcrB and MmpL3, two proteins commonly targeted by compounds
identified in phenotypic screens in Mtb. Thus, it is possible that the nitro 1,2,4-triazole series represents a new
mechanism of action (MOA) for inhibition of Mtb. To begin to investigate how the nitro-1,2,4-triazoles inhibit Mtb,
we selected for resistant mutants and identified resistant isolates with mutations in genes required for coenzyme
F420 biosynthesis and the nitroreductase Ddn. These mutants are also resistant to pretomanid, a prodrug that
requires activation of its aromatic nitro group by F420-dependent-Ddn activity in order to exert anti-Mtb activity.
We predicted that our nitro 1,2,4-triazoles are similarly activated by Ddn. Therefore, in an effort to circumvent
the need for activation, we performed structure activity relationship (SAR) analyses and discovered that
replacement of the nitro groups in the phenyl ring on the 1,2,4-triazole core with chloro retained activity against
WT Mtb and avoided loss of activity in F420 and Ddn mutants. Thus, the chloro-containing 1,2,4-triazoles
circumvent the predominant resistance mechanism against aromatic nitro-containing compounds. We also
examined core modifications that would retain anti-Mtb activity and discovered that the 1,2,4-triazole core can
be replaced with a chiral pyrrolidine core and retain the same activity. This led us to hypothesize that the core is
a “spacer” linking the other parts of the molecule. Since the core structure defines the compound class, our SAR
method has now resulted in a second new class anti-Mtb agents that will act as a bioisostere with similar steric
volume and retained hydrogen-bond donor/acceptor atoms as the 1,2,4-triazole series. The increased sp3
character of the pyrrolidine scaffolds could be advantageous over the 1,2,4-triazole scaffold in terms of a more
diverse chemical space that has been shown to translate to enhanced clinical success. Our objectives are to
demonstrate preclinical proof-of-concept for the 1,2,4-triazole and pyrrolidine compounds to combat Mtb infection
and optimize lead compounds for pharmacologic properties required for translation to a therapeutic. Based on
our preliminary data, we hypothesize that the 1,2,4-triazole and pyrrolidine compounds operate through a unique
MOA as compared to other antibiotics and, therefore, dissecting their mode of inhibition will also reveal new
biological insight into Mtb physiology and pathogenesis.

Public health relevance
PROJECT NARRATIVE Mycobacterium tuberculosis (Mtb) infection is the leading cause of death due to infection globally. This epidemic is exacerbated by the rise in drug-resistant TB cases, making it clear that we need new strategies to fight these infections. The proposed studies will develop novel antimycobacterials to be used in the treatment of drug- sensitive and drug-resistant TB.